Translational and Clinical Research (TACR)

The Translational and Clinical Research (TACR) Program catalyzes collaborations along the laboratorytranslational-clinical research continuum and across solid tumor disease sites in the University of Michigan (UM) Rogel Cancer Center (Rogel). TACR represents a crucial bridging mechanism for the Rogel, linking its
laboratory and population science based-research programs that generate innovative concepts, agents, and
approaches that TACR translates to solid tumor patient-oriented research. The TACR program has three
Specific Aims: 1) Develop and apply state-of-the-art molecularly targeted approaches to cancer diagnosis and
treatment; 2) Develop and test new predictive biomarker and disease-monitoring strategies across tumor
types; and 3) Advance concepts emanating from Rogel Cancer Center scientific programs to impactful clinical
trials.